Genetic of Kidney Disease and Hypertension in MVP II

Chronic Kidney Disease (CKD) is a global public health issue, affecting 1 in 7 adults in the United States and 850
million people worldwide. In addition to the risk of progressing to end-stage renal disease (ESRD), a life-
threatening condition with a devastating impact on quality of life, CKD is associated with a high-cost burden to
the healthcare system and high mortality. However, therapies to slow progression remain scarce. A major barrier
for discovery of disease mechanisms and therapeutic targets in CKD is the heterogeneity of disease progression
and outcomes, even within specific etiologies such as diabetic kidney disease (DKD), arterionephrosclerosis, or
glomerular diseases. While the genetic contribution to kidney disease has been characterized in cross-sectional
designs and mostly using estimated glomerular filtration rate (eGFR), there remains a significant gap in
knowledge of the genetic contributors to disease progression and for some CKD subtypes. In this application, we
propose to address these limitations by creating a comprehensive model of CKD progression centered on
genetics that integrates kidney biopsy data, highly curated clinical phenotypes, and state-of-the-art omics
methodologies, including genomics, methylation, proteomics, and gene expression. This will provide deeper
understanding of mechanisms of CKD, while overcoming the phenotypic heterogeneity traditionally seen in CKD
and the limitation of using cross-sectional designs of eGFR. This, in turn, will foster the discovery of disease
mechanisms, identify therapeutic targets so desperately needed, and inform risk prediction. Additionally, we will
continue researching second hits for APOL1-mediated kidney disease (AMKD). Diet has been considered
potentially a second hit for AMKD and APOL1 effect on blood pressure. Diet is a critical and modifiable
determinant of CKD progression. To this end, we will study gene*diet interactions as a modifiable determinant
of CKD progression, hypertension. We will accomplish these goals through the following aims: 1) To curate the
“VA e-Kidney biopsy repository” by defining kidney phenotypes using kidney biopsy data nationally and in MVP.
We will generate an algorithm for kidney biopsy results based on structured data and automated information
extraction using natural language processing from the report or clinical notes. We will integrate urinary
biomarkers: proteinuria, albuminuria, hematuria, specific gravity, 24-hour urine collection. We will collaborate
with VHA Program for Kidney Medicine. 2) To perform GWASs and whole genome analysis of CKD progression
in non-diabetic CKD and incident DKD by ancestry in MVP. Disease progression outcomes will include a) eGFR
slope, b) a composite of 40% decline in eGFR or ESRD15, and c) rapid decline >3 ml/min per 1.73m2 per year,
in MVP. We will also study CKD subtypes with histological diagnosis and imaging when possible. Risk factors
for CKD will be explored using Mendelian randomization analyses for causal inference (mineral metabolism,
etc). Polygenic risk scores will be used for prediction models of progression. Gene expression analyses will
prioritize identified variants relevant to CKD. 3) To study gene*nutrient interactions (micro- and macro-
nutrients: salt, potassium, oxalate, plant vs. non-plant protein, etc), derived from the MVP lifestyle survey. 3.a)
Gene*nutrient interactions are studied as important determinants of CKD progression, kidney stones, and blood
pressure. 3.b.) APOL1 mechanism-driven interactions influence pathways related to kidney health,
e.g., APOL1*salt intake, blood pressure, and CKD. Sub-aim 3.b will help to inform further the value of APOL1
testing and dietary recommendations for CKD care. Identifying additional ancestry-specific variants and
interactions remains essential to continue progressing toward diminishing long-standing inequities in CKD. Our
project will provide a step forward in understanding the pathophysiology of CKD through genetics, inform new
drug targets, and improve risk prediction and will offer several avenues of applying genomics into medicine to
improve the care we provide for patients with CKD. Replications will be pursued in BioVU, All of Us, UKBB, and
eMERGE.

Public health relevance
Chronic Kidney Disease (CKD) is a major global health problem, affecting 850 million people worldwide. In addition to the risk of progressing to end-stage renal disease (ESRD), a life-threatening condition with a devastating impact on quality of life, CKD is associated with high mortality. However, therapies to prevent CKD progression remain scarce. We here propose creating a comprehensive model of CKD progression that integrates kidney biopsy data, clinical phenotypes, and state-of-the-art omics methodologies (genomics, etc.). To foster discovery and new therapeutic development. We continue to work on genetic variants like APOL1 involved in health disparities to continue to make progress in decreasing the inequity observed in CKD and study environmental factors like diet that can interact with APOL1 and other genes that promote CKD progression and hypertension. These discoveries have direct implications for improving hypertension, CKD progression and health.